Predoctoral Training in Molecular Pharmacology

Project Summary
The Molecular Pharmacology Training Program is an interdisciplinary training program centered in the
fundamentals of pharmacology. The mission of the MPTP is to develop innovative scientists with a strong
foundation in pharmacological principles and skills required for the modern workforce. Our vision is to provide
our trainees with 1.) an efficient structured path through the PhD, 2.) a strong focus on therapeutics, and 3.)
excellent career and professional development activities. To accomplish our vision, the program focuses on 6
key competencies for our trainees: comprehension of pharmacology, professionalism, creativity, critical
thinking, communication, and collaboration. To put this into practice, we also focus on developing strong
mentoring competencies for our trainers through required mentor training and ensure that they are aligned with
the vision of the program. The Pharmacology PhD program serves as the overall structure for the MPTP. To
meet the growing demand for PhD scientists with a strong training in therapeutics, the MPTP has created a
curriculum to augment the student’s training in related disciplines (neuroscience, biochemistry, etc). The 45
MPTP preceptors reflect this interdisciplinary approach to training as they represent five major research
centers in Cleveland: CWRU School of Medicine, University Hospitals, Cleveland Clinic, MetroHealth Medical
Center, and the Louis Stokes VA Medical Center. The curriculum is rigorous with clearly defined metrics that
are rooted in the 6 core competencies. Training activities are designed to bring cohorts of students who are
interested in therapeutics across the city of Cleveland together in shared experiences. The MPTP fosters
career exploration with workshops and classes that expose students to available resources early in their
training, which allows them to tailor their program of study to meet their career goals. Our desired outcomes
are to graduate PhD scientists with the knowledge base and research skills to pursue a broad range of career
opportunities related to pharmacology, ranging from academic and industrial bench science to scientific writing,
patent law, science policy, biotech management, and teaching. We also seek to combat the increasing time to
degree by modernizing the approach to PhD education through an intentionally designed program that is
efficient, yet rigorous. Our goal is to be a model for other PhD programs at CWRU School of Medicine and
across the country.

Public health relevance
Project Narrative The Molecular Pharmacology Training Program (MPTP) provides a rigorous education in the principles of pharmacology and laboratory training by leveraging an interdisciplinary collection of trainers from multiple departments and institutions affiliated with Case Western Reserve University School of Medicine. The structured program is designed to develop critical thinking, problem solving skills, and scientific knowledge to develop the next generation of leaders in pharmacology. The training program has a distinct focus on career and professional development to prepare students for a multitude of careers that take full advantage of their specialized training in pharmacology.